Tongue maturation deficits in a mouse model of Down syndrome

Abstract
Atypical and delayed oromotor development is a well-known clinical aspect of Down syndrome (DS) and
contributes to devastating challenges in speech, feeding, and swallowing. These challenges can affect the
majority of individuals with DS, with profound consequences for quality of life and health. The tongue and
brainstem are both complex systems that undergo rapid changes during early postnatal development and are
critical for speech and swallowing. However, the central and peripheral changes occurring in early childhood
that permit postnatal expansion in movement and function of the tongue are poorly understood in typical
development and in DS. This proposal is for an administrative supplement to the INCLUDE-funded parent
grant, “Tongue maturation deficits in a mouse model of Down syndrome”, which tests the central hypothesis
that DS is associated with developmental delays in maturation of the tongue neuromuscular system. The
parent grant uses the Ts65Dn mouse model of DS exclusively to generate normative data for the study of
tongue and brainstem maturation at early postnatal ages and will determine how DS impacts lingual
development. This is achieved through behavioral and immunofluorescence studies of tongue muscles and
brainstem. However, new animal models of DS with superior genetic verisimilitude to DS have now become
available. The proposed supplement work will expand a key subset of the parent grant goals to incorporate the
new Ts66Yah mouse model of DS (Supplement Aim 1a). This supplement aim will further the science
underlying both typical and delayed lingual maturation. As such, this work will provide basic knowledge for
future efforts to develop biologically based approaches for successful resolution of pediatric oromotor disorders
that impact children with DS. These goals will establish an experimental framework to advance biologically
informed treatments for developmental speech, feeding, and swallowing disorders. This application addresses
the NIH INCLUDE Component 1: Targeted high risk – high reward basic science studies in areas highly
relevant to DS.

Public health relevance
PROJECT NARRATIVE Down syndrome (DS) is associated with atypical tongue movement that contributes to devastating challenges with communication and feeding, but the biological mechanisms underlying these challenges are not known. This supplement research will investigate early postnatal changes in tongue muscles and brainstem in a new mouse model of DS at two different timepoints during oromotor development.